Insights into a multi-hit process in the development of necrotizing enterocolitis

Necrotizing enterocolitis (NEC) is a devastating intestinal inflammatory disease that primarily affects
premature infants and extremely low birth weight babies. Commonly observed risk factors for NEC are
prematurity, formula feeding, intestinal dysbiosis, and infection. Previous studies strongly suggest a critical role
of the inappropriate microbiome colonization and activation neonatal immune system in NEC development.
However, the pathogenesis of NEC is elusive. Particularly, it remains unclear how the NEC-associated risk
factors contribute to the disorder. In preliminary studies, we characterized the effect of formula-feeding on
intestinal flora, gene expression, and immunobiology in neonatal mice. We also examined intestinal pathology
of mouse pups which were fed with formula followed by induction of a particular antimicrobial immune response.
We found that formula-feeding alone resulted in a distinct type of gut dysbiosis and pre-NEC intestinal molecular
changes that predispose the neonatal gut to inappropriate microbiome colonization/infection and render intestinal
mucosa to be a target of cytotoxic inflammatory cells. We further revealed that formula-fed but not dam-fed
mouse pups developed NEC upon activation of a cytotoxic inflammatory cell-associated antimicrobial immune
response. Thus, it appears that NEC develops following inappropriate microbiome colonization in premature
infants as a consequence of “multi-hit pathophysiological events”. In this project, we will study new mechanistic
insights into these events and determine how the interaction of multiple-hit events contributes to the development
of NEC in two complementary aims: (1) We will first characterize the series of pathophysiological events that
leads to NEC development, using a novel and pathologically relevant mouse pup model of NEC and up-to-dated
in vivo experimental pathological and immunological approaches. Then, we will use RNAseq and cutting-edge
bioinformatic analysis to delineate the transcriptomic response of the small intestine of mouse pups to multiple-
hit challenges and to unravel the relevance of this novel mouse model of NEC for human NEC. Furthermore, we
will study how major NEC risk factor-induced “multi-hit events” contribute to NEC development by focusing on
inflammatory cells, mucosal inflammation-associated inflammatory mediators, and a unique signal axis that
protects intestinal epithelial cells against inflammatory cell attack. We will achieve this aim using in vivo
experimental approaches that draw on molecular biology and mouse genetic engineering techniques. (2) We will
elucidate how formula feeding causes pre-NEC molecular changes in the small intestine of premature neonates
by taking a multidisciplinary in vivo and in vitro approaches that incorporate techniques of organoid culture,
molecular and cellular biology, microbiology, mouse genetic engineering and gnotobiogy. Together, our work will
provide a novel mouse model relevant for human NEC, advance knowledge of how the interaction between NEC
risk factors and activation of the neonatal immature immune system triggers NEC development, and gain
mechanistic insights that will inform the development of new strategies for the prevention and treatment of NEC.

Public health relevance
NEC is a serious intestinal disease that primarily affects preterm infants and is a leading cause of death among premature infants in the United States. In this project, we will address fundamental questions about why and how NEC occurs in a group of high risk premature babies upon postnatal exposure to NEC-associated environmental factors in combination with activation of antimicrobial immune responses. The knowledge generated is expected to pave the way for the development of novel therapies to prevent and treat NEC.